Cooperative Human Tissue Network Eastern Division

ABSTRACT
The core mission of the Cooperative Human Tissue Network (CHTN) has been to serve the
public good by fostering biomedical research through collecting and supplying high quality, well-
characterized human biospecimens to the scientific community. The proof of our success over
the past 36 years is evidenced by the growing bibliography of 5000 publications and 272
published patent applications by the researchers (CHTN investigators) using our service. The
CHTN Eastern Division (ED) has built a dynamic infrastructure and brought the CHTN resource
to over 1000 researchers who otherwise would have lacked access to the tissue essential to
their work. The purpose of this proposal is to report the successes, strengths, and innovations of
the ED at the University of Pennsylvania (UPENN) and to present our plan to continue as an
adult division of the CHTN in the next 5-year cycle. The Specific Aims of the ED were developed
as the operational blueprint for this division to maximize participation in the national CHTN by
leveraging local resources. To this end, our Aims, highly successful to date, refresh and
reinforce our highly unified approach to procedures, informatics, and operations to ensure
procuring and supplying premium quality biospecimens with personalized customer service. The
Specific Aims of the ED will remain consistent in the proposed funding cycle because they
continue to reflect the innovative approach to collection, quality management, and distribution of
biospecimens, the core of the CHTN Mission.

Public health relevance
Cooperative Human Tissue Network Eastern Division NARRATIVE CHTNED provides high quality human bio specimens to support research in cancer, autoimmunity, and other classes of human diseases. These research projects advance understanding of disease development leading to new diagnostic and therapeutic modalities. These in turn benefit public health by allowing screening procedures for diseases in preclinical asymptomatic stages and defining new therapies to patients with fully developed and even late stage disorders.